Differential targeting of von Willebrand factor depending on oxidizing conditions

Project Summary / Abstract
The blood protein von Willebrand factor (VWF) is a large multimeric protein that, when activated, binds to
blood platelets tethering them to the site of vascular injury initiating blood coagulation. This process is critical
for normal haemostasis, but especially under inﬂammatory conditions it is thought to be a major player in patho-
logical thrombus formation. For this reason, VWF has been the target for the development of anti-thrombotic
therapeutics. However, a particular challenge is how to prevent pathological thrombus formation while still allow-
ing normal physiological blood coagulation. In fact, currently available anti-thrombotic therapeutics are known
to cause intracranial bleeding as side eﬀect. The work presented here proposes that by identifying the confor-
mational changes that VWF undergoes in inﬂammation it will be possible to design molecules that target VWF
selectively only in an inﬂammatory pro-thrombotic environment. Experiments performed in vitro have indicated
that oxidizing agents released during inﬂammation increase the platelet-binding activity of VWF, and this has
been linked to the oxidation of methionine residues within VWF. This study aims to characterize what inhibitory
mechanisms are removed in VWF through methionine oxidation and identiﬁes sites that can be targeted optimally
under oxidizing conditions. We hypothesize that oxidation activates the A1 domain (the domain in VWF that
contains the binding site to platelets) by removing the masking function of its neighboring domains. Through
a combination of a dynamic ﬂow assay, equilibrium unfolding experiments and a binding assay, we will identify
which auto-inhibitory mechanisms of VWF are turned oﬀ by oxidation and which methionine residues are key for
activation under oxidizing conditions. This knowledge will then be used in computational docking studies to create
a model of the complex between the A1 domain and its neighboring domains and study the structural eﬀects of
methionine oxidation at atomic level of detail. An assay using samples from patients with inﬂammatory conditions
will be used to test the link between inﬂammatory conditions and higher activity of VWF in vivo. The structural
insights gained here will be invaluable to structure-based drug design in order to develop therapeutics that target
VWF only when it is in its oxidized state in order to prevent thrombosis while allowing haemostasis.

Public health relevance
Project Narrative Inﬂammation causes the release of oxidative agents, which activate blood coagulation proteins leading to a pro- thrombotic state. The work proposed here investigates the structural basis of how oxidation activates von Wille- brand factor, a key protein in the initial stages of blood coagulation. The results will help the structure-based design of therapeutics that are able to prevent thrombosis while minimizing the risk of unwanted bleeding.